Statistical Power Analysis Framework for Multi-Sample and Cross-Platform Spatial Omics Experiments

Abstract
Recently, high-throughput spatial omics technologies have made it possible to simultaneously measure close-
to-cell-level gene or protein expressions and spatial locations of these cells within a tissue or organ. These new
technologies have provided an unprecedented opportunity to investigate tissue architecture and cell-cell
communications. Although multiple computational tools for spatial omics data analysis have recently become
available, a rigorous statistical framework for designing spatial omics experiments is still missing in the literature.
Researchers need to determine various experimental design parameters, such as the sequencing depth and the
number and sizes of Field-Of-View (FoV), in planning a spatial omics experiment. These choices affect whether
key goals of spatial omics experiments can be achieved, e.g., identification of tissue architecture and cell-cell
communications. In this proposal, we aim to develop a rigorous power analysis framework for spatial omics
experiments across various experimental designs and profiling technologies. The assembled team has strong
and complementary expertise in development of statistical frameworks for power analysis and design of high
throughput sequencing studies, statistical modeling of spatial omics and scRNA-seq data, technology
development in spatial omics, spatial statistics, bioinformatics tool development, pulmonary science, and lung
fibrosis and relevant age-related mechanisms. We will achieve the proposed goal by implementing three specific
aims. In Aim 1, we will develop a rigorous power analysis framework for multi-sample and longitudinal
sequencing-based spatial transcriptomics experiments (e.g., 10X Genomics Visium). In Aim 2, we will develop
a statistical power analysis framework for imaging-based spatial transcriptomics and proteomics experiments
(e.g., seqFISH+, MERFISH, CODEX) in single- and multi-sample and longitudinal settings. In Aim 3, we will
develop an interactive web interface for power analysis of spatial omics experiments and utilize and validate it
for designing spatial omics experiments for lung cells. The proposed power analysis framework will be developed
and evaluated using simulation data, spatial omics data in the public domain, and in-house spatial omics datasets
from collaborators. The to-be-developed statistical framework in this project, along with the open-source software
implementing this framework, will provide essential tools for the optimal design of future spatial omics
experiments.

Public health relevance
Narrative Newly emerging spatial omics experiments can promote our understanding of spatial and molecular patterns and relevant biological mechanisms associated with various organs and diseases such as cancers and neurodegenerative disorders. The proposed power analysis framework will help improving design of spatial omics experiments, which in turn will help guarantee biologically meaningful findings. The high impact of this framework will be reflected through an interactive web interface with a coding-free environment that will assist basic scientists, clinical scientists, and bioinformaticians in their design of spatial omics experiments.